Innate Immune Memory: From Evolutionary Roots to Human Disease

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Innate Immune Memory: From Evolutionary
Roots to Human Disease, organized by Drs. Mihai G. Netea, Shabaana A. Khader and Triantafyllos Chavakis.
The conference will be held in Banff, Alberta, Canada from March 6-9, 2022.
Memory characteristics of innate immune responses (also termed ‘trained immunity’) have been recognized
only recently, with a multitude of studies demonstrating their importance for long-term broad protection against
infections. Innate immune memory has been demonstrated to have deep evolutionary roots in plants and
invertebrates, but also plays an important role in the host defense of vertebrates in general, and mammals in
particular. In humans, innate immune memory is important for host defense against infections, and may
enhance anti-tumor immunity, but can also contribute to pathogenesis in inflammatory and autoimmune
diseases. The emergence of novel types of immunotherapy is having a profound impact on disease outcomes
in several major pathologies such as cancer, autoimmune diseases and even severe infections. However, the
immunotherapeutic research has largely focused on targeting adaptive immune cells (e.g., checkpoint
inhibitors, CAR-T cells, monoclonal antibodies), with relatively little attention to innate immune cells. This
conference intends to change this by serving as an international forum to highlight innate immune processes of
relevance to immunotherapies. This meeting is a unique platform, in which researchers from several important
fields (immunology, evolutionary biology, cancer biology, infectious diseases and physiology, clinical and
health sciences) will be able to interact and exchange ideas, methods and build collaborations: this is emerging
as one of the most exciting areas in immunology, and the proposed Keystone Symposium has the chance to
give a strong impetus to this novel field of research.

Public health relevance
PROJECT NARRATIVE In humans, innate immune memory is important for host defense against infections and promotes anti-tumor immunity but can also contribute to the pathogenesis of inflammatory and autoimmune diseases. This conference will serve as a unique platform during which researchers from several relevant fields (immunology, evolutionary biology, molecular biology, physiology, clinical sciences) can interact and exchange ideas, share methods and build collaborations. Furthermore, the conference will provide the ideal environment for the emergence of a new generation of scientific leaders in the field.